Adaptive Messaging to Support Depression Self-Management

Summary
Automated messaging has significant potential to extend access to guidance and support for those managing
common mental health conditions like depression. However, benefits of automated messaging could be
improved through building capacity to automatically adapt messaging approaches to users’ needs. The PI’s
career goal is to establish scalable digital mental health interventions that deliver individualized communication
to maximize users’ engagement in effectively managing mental health concerns. This proposal outlines training
and research plans to achieve this goal, culminating in a successful R01 proposal. The training plan takes full
advantage of the strong institutional support and environment at Northwestern University's Feinberg School of
Medicine and the Center for Behavioral Intervention Technologies, which is led by the primary mentor for this
proposal. Training goals necessary to the PI’s career goal include growth in (1) user-centered design, (2)
adaptive interventions, and (3) clinical science methodologies. This proposal builds on the PI’s background in
communication science, which has focused on effective message design and social support provision. In this
K01, the PI will aim to develop a model for delivering automated, individualized self-management support for
depression, emphasizing messaging that can accommodate fluctuations in users’ motivations and abilities to
carry out cognitive and behavioral self-management strategies. This will be achieved through the following
specific aims: (1) conduct user-centered design activities and usability testing to design and refine a
messaging system; (2) integrate a reinforcement learning algorithm into the system that adapts content to
users and their contexts; and (3) pilot procedures and analyses for a randomized controlled trial and obtain
preliminary evidence of the intervention’s effectiveness and mechanisms of action. For Aim 3, I will test
hypotheses that messaging interventions will result in greater reduction in depression than a waitlist control
group, and that adaptive messaging will reduce depression relative to non-adaptive messaging by producing
greater engagement in self-management. This research is expected to advance the design of messaging
interventions for depression, ultimately extending the reach and effectiveness of these interventions. Skills
acquired by carrying out the research proposed in this application will allow the PI to successfully compete for
R01 funding in order to conduct a larger effectiveness trial.

Public health relevance
Narrative Technology-based interventions hold promise to extend the availability of support for individuals managing mental health concerns, but their success requires keeping users engaged over time. This K01 proposal leverages machine learning to establish a messaging intervention that can automatically adapt communication styles to accommodate users’ individualized support needs and preferences and their fluctuations over time. If successful, this project will lead to a scalable intervention model that delivers engaging, personalized support while imposing low burden on users and the health system, and that could be broadly applied to address a wide variety of mental health conditions.